Visual stimulator for congnitive evoked-response QSD

[unreadable] DESCRIPTION (provided by applicant): A new method for recovering superposed waveforms when the evoked-response is longer than the interval between stimuli has been recently invented. The new method is called QSD (q-Sequence Deconvolution). QSD can recover brain responses not previously observed because standard evoked-response technique is limited to responses shorter than the period of the stimulus repetition-rate. This project will build a visual stimulator for recording superposed VEPs (Visual Evoked Potentials). The project will then test whether the VEP responds at stimulus repetition-rates, which overlap the VEP. If it does, then the potentials may differ from those seen at slower [unreadable] stimulation rates. [unreadable] [unreadable] The project will also test whether stimuli more complex than checkerboards provide any [unreadable] additional measure of brain function. [unreadable] [unreadable] This project is health related because evoked-responses are widely used for screening and [unreadable] diagnostic testing. If the stimulator provides previously-unrecorded VEPs, then it is possible [unreadable] that such potentials could be of scientific and clinical use. Because the potentials are obtained [unreadable] from scalp electrodes it is easy to utilize such evoked-responses for clinical testing. [unreadable] [unreadable] [unreadable]